Quantitative imaging of choroid plexus function and neurofluid circulation in Alzheimer's Disease Related Dementia

PROJECT SUMMARY
The goal of this work is to refine neuroimaging methods to enable quantitation of choroid plexus (ChP) anatomy
and function non-invasively in vivo, and subsequently to use these methods to test fundamental hypotheses
regarding ChP activity, cerebrospinal fluid (CSF) flow, and anatomical and protein markers of molecular
clearance dysfunction in patients with Alzheimer’s Disease Related Dementias (ADRDs). The premise for this
work is based on the known role of the ChP complexes for CSF production, and the recent link between
bulk and perivascular CSF flow dysfunction in neurodegenerative disorders, yet a lack of robust
methods for quantifying these pathways in humans. We have shown that arterial spin labeling (ASL)
magnetic resonance imaging (MRI) methods and deep learning algorithms can be re-parameterized to enable
reproducible estimates of ChP perfusion (ml/100g/min) at high spatial resolution and accurate automated
localization, respectively: in preliminary data from 139 volunteers, we have (i) demonstrated abilities to
obtain reproducible ChP perfusion estimates in healthy adults (n=10); (ii) observed that improvements
in vascular health reduce ChP activity (n=23) and progressive intracranial vasculopathy increases ChP
perfusion (n=75); and (iii) report here that in older adults with ADRDs, ChP is elevated relative to age-
matched adults without dementia (n=31). These data highlight the possibility of evaluating ChP function in
vivo in neurodegenerative and cerebrovascular disease. However, extant methods require refinement to improve
ChP localization and quantitative accuracy, including an expanded knowledge of ChP physiology and how ChP
activity relates to anatomical markers of molecular clearance and symptomatology. Here, we propose to address
these gaps in our understanding. In Aim (1), we will perform systematic measurements of ChP MRI relaxation
times and circulatory dynamics; findings will improve ChP perfusion accuracy beyond current approaches that
utilize convenience calibration values from other tissues. In Aim (2), we will extend prior studies demonstrating
circadian variation in CSF production to quantify diurnal variation in ChP perfusion during sleep and wakefulness;
results will serve as a necessary prerequisite for future studies that utilize ChP function as a surrogate or
complement to glymphatic or CSF flow dysfunction. In Aim (3), we will quantify ChP perfusion in participants
with ADRD in sequence with bulk CSF flow velocity through the cerebral aqueduct, parasagittal dural volume,
and proteinopathy. Data will be used to test fundamental hypotheses regarding the relevance of ChP activity and
impaired trans-molecular passage in the setting of normal and heightened amyloid burden and clinical dementia.
Findings will provide the first data on how ChP activity, quantified non-invasively in vivo from high
spatial resolution perfusion MRI, reflects variation in traditional or novel fluid efflux. Successful
completion will provide new acquisition and post-processing resources, which will provide a foundation
for using these methods in the growing number of applications of CSF clearance dysfunction.

Public health relevance
NARRATIVE Neurofluid circulation has gained much attention in light of its likely relevance to neurodegenerative and cerebrovascular disorders, including but not limited to Alzheimer’s Disease Related Dementias (ADRDs). Fundamental to the effective circulation of neurofluids is cerebrospinal fluid (CSF) production activity, which occurs within the choroid plexus (ChP) complexes located within each of the four brain ventricles; despite this, we lack rigorous and quantitative methods for quantifying ChP activity, thereby limiting abilities to evaluate CSF circulation in different neurodegenerative disorders, as well as in response to emerging therapies. The overall goal of this work is to refine and clinically evaluate neuroimaging methods to enable quantitation of ChP anatomy and function non-invasively in vivo; if successful, this will allow for ChP function to be interrogated reliably in the growing number of applications where neurofluid and CSF circulatory dysfunction are implicated.